The role of area V4 in the perception and recognition of visual objects

ABSTRACT
In cluttered natural visual environments object recognition capacity can be severely limited. This may reflect
limitations associated with the visual cortical encoding of multiple nearby stimuli. Alternatively, poor object
recognition in clutter, especially profound in patients with autism, may result from limited resolution of
attentional control and object decoding that rely on interactions between visual cortex and frontal cortex. We
do not know what neuronal mechanisms limit object recognition in crowded scenes because
neurophysiological studies typically present one or two stimuli at a time, and are thus free from the constraints
imposed by clutter in natural scenes. In addition, studies seldom investigate the role of visual-frontal
interactions in object recognition. We will use a combination of single neuron studies in awake monkeys,
behavioral manipulations, reversible inactivation and computational modelling in two mid-level stages of visual
cortex, V2 and V4, and the prefrontal cortex (PFC), to determine: (Aim 1) how V2 and V4 neurons encode
visual stimuli in the presence of clutter, and how the encoding depends on eccentricity and on attentional
engagement; (Aim 2) how PFC feedback influences encoding in V2 and V4, and how these brain regions
together contribute to shape discrimination in clutter. We will consider three hypotheses. First, visual encoding
may have limited resolution in clutter: when many objects are nearby, regardless of what those objects are, the
visual system may fail to segment and encode individual objects. Second, processing in mid-level stages may
be designed to encode only salient objects, i.e., objects that exhibit sufficient feature contrast relative to
neighboring image regions. In this case, loss of information may pertain to objects in homogeneous image
regions reflecting a representational strategy to preferentially encode objects that stand out. Third, it is possible
that all objects are segmented and encoded faithfully, even in clutter, but the capacity limits are dictated by the
resolution of attention or other downstream processes that influence object decoding. Our studies will address
a fundamental gap in the understanding of how multi-objects displays, which dominate natural vision, are
encoded in mid-level visual cortex. They will reveal how encoding strategies vary across eccentricity and this
could be relevant for diseases like age-related macular degeneration, where foveal representations are
compromised selectively. Finally, our results will provide fundamental insights into how V4 and PFC
communication is critical for object recognition in clutter and how diminished communication between the two
could influence behavior. This could be important for guiding translational work on autism spectrum disorder.

Public health relevance
PROJECT NARRATIVE We will use a combination of primate neurophysiology experiments, computational modeling, animal behavior and reversible inactivation methods, to achieve a new level of understanding about how cluttered visual displays are encoded in visual cortex and how interactions between visual cortex and prefrontal cortex facilitate object recognition in clutter. These findings will ultimately bring us closer to devising strategies to alleviate and treat brain disorders of impaired object recognition resulting from dysfunctions in the occipito- temporal pathway (e.g. agnosia) and from diminished communication between visual and prefrontal cortex (e.g. autism).